Mentoring Clinical Researchers at the Intersection of NeuroHIV and Substance Abuse

Project Summary
This is a renewal application for a K24 Midcareer Investigator Award in Patient-Oriented Research to support
my ability (1) to attract scientists to patient-oriented research at the intersection of neuroHIV and substance use,
(2) to prepare a new crop of investigators to tackle complex research questions that require translational
approaches and interdisciplinary collaboration, and (3) to diversify the composition of the scientific workforce in
order to increase creativity, insights, and representation of problem-solving approaches. Mentoring and training
will be integrally tied to my own research and to the major projects within the HIV Neurobehavioral Research
Program (HNRP) at the University of California, San Diego, which are rich sources of data, specimens, and
research infrastructure. Mentees will also have access to didactics made available by training programs in which
I participate, such as the R25 Interdisciplinary Research Fellowship in NeuroAIDS, which I direct, and a T32
program for Training in Research on Addictions in Interdisciplinary NeuroAIDS, where I am a faculty mentor. I
plan to involve mentees in developing new research directions in medical applications of cannabinoids for
neuroHIV and explore predictors of central nervous system outcomes in Latinos who recover from COVID-19. I
will also involve mentees in my continued work on individual differences in vulnerability to CNS dysfunction
associated with stimulant use in the context of HIV. I propose additionally to pursue my own professional
development to continue to improve my skill set in mentoring trainees from underrepresented and disadvantaged
backgrounds, as well as to enhance my leadership skills. The superb research environment of the HNRP, along
with the larger UCSD HIV and substance use research community, affords excellent opportunities for mentoring
and fostering the advancement of early career clinically oriented scientists.

Public health relevance
HIV infection continues to be a cause of neuropsychological impairment for which there are currently no treatments. Support from a K24 Midcareer Investigator Award in Patient-Oriented Research will allow me to develop mew research directions while mentoring clinically-oriented scientists from diverse backgrounds to prepare them for translational research at the intersection of neuroHIV and substance use.